Elucidation of the Mechanism of Microhomology-Mediated End Joining by DNA Polymerase Theta

PROJECT SUMMARY
Double-stranded DNA breaks (DSBs) are a severe form of DNA damage that can give rise to devastating
chromosomal aberrations. While DSBs are usually repaired with high fidelity through homologous recombination
(HR), cells bearing mutations in HR-associated genes such as breast cancer related genes (BRCA)1/2, pivot to
a non-classical DSB repair process called microhomology-mediated end joining (MMEJ). Unlike HR, MMEJ is
highly error-prone and can lead to genomic instability and carcinogenesis. A key player in MMEJ is DNA
polymerase theta (PolΘ), which is recruited to DSBs to carry out the DNA microhomology annealing, strand
separation, and gap-filling processes via a unique DNA DSB repair mechanism that remains poorly understood.
Many cancers, such as BRCA1/2 deficient breast, ovarian, prostate, and pancreatic cancers, exhibit HR pathway
deficiencies and rely heavily on MMEJ, making PolΘ a promising therapeutic target due to its fundamental
involvement in this DNA repair pathway. Successful targeting and inhibition of PolΘ to treat HR-deficient cancers
requires a mechanistic understanding of how PolΘ coordinates MMEJ. To gain new biomedically impactful
insights into these unknown mechanisms, I will combine established biochemical and cell-based assays with
innovative gene editing and structural biology approaches to elucidate the molecular mechanism of MMEJ and
identify intramolecular and intermolecular interactions that are indispensable for efficient MMEJ by PolΘ. During
my first year in the Lander lab, I determined the first DNA-bound structure of the PolΘ helicase domain using a
DNA substrate I identified with a native PAGE screen. This structure reveals the isolated PolΘ helicase domain
performing microhomology annealing, which is the primary initiation step of MMEJ. This structure also reveals
how DNA is threaded through the helicase during MMEJ, a shift in helicase quaternary structure from tetramer
to dimer, and a hinged rotation of both helicase C-terminal domains to accommodate DNA microhomology
annealing between the protomers. These observations provide novel insights into the role of the PolΘ helicase
domain in MMEJ. These preliminary data establish a solid foundation for my studies aimed at (Aim 1) defining
the atomistic relationship between PolΘ and MMEJ DNA substrates and illuminating novel strategies for
development of PolΘ-targeted therapeutics to treat HR-deficient cancers, and (Aim 2) elucidating the cellular
mechanism of MMEJ and investigating cellular consequences of my structural and biochemical insights. These
combined biological and technical studies will address a critical unmet need in BRCA1/2-mutant breast and
ovarian cancers by revealing new strategies for development of PolΘ inhibitors to be investigated as potential
therapeutics for treating HR-deficient myopathies.

Public health relevance
PROJECT NARRATIVE Harmful DNA breaks caused by exposure to radiation, chemicals, or as a result of mistakes that occur when DNA is being duplicated are usually repaired accurately through a process called homologous recombination (HR). When a DNA break occurs in an HR-deficient cell, it triggers a highly error-prone, cancer- inducing backup DNA repair pathway called microhomology-mediated end joining (MMEJ), and cells produce large amounts of the protein that performs MMEJ: DNA polymerase theta (PolQ). My project will uncover the step-by-step mechanism of how PolQ performs MMEJ and inform new strategies for discovering molecules that inhibit PolQ function to be investigated as potential HR-deficient cancer drugs.